Metabolic Regulation of Natural Killer Cell Activation

Project Summary
The long-term goal of this project is to determine the metabolic regulation of NK cell effector functions to
improve our understanding of basic mechanisms of NK cell activation in health and disease. Natural killer (NK)
cells are innate immune lymphocytes that serve as a critical first line defense against infection, particularly
viruses, and are important for tumor immunosurveillance. NK cells mediate their effects via two mechanisms:
production of cytokines (especially IFN-gamma) and target cell killing. NK cell effector functions can be
triggered by inflammatory cytokines or engagement of germline-encoded activating receptors whose ligands
are displayed by infected and/or tumor cells. Metabolic regulation plays a key role in many aspects of
immunity, including in NK cell response to viral infection. We previously demonstrated that stimulation of
naïve, fresh NK cells through cytokines versus activating receptors has differential metabolic requirements,
with activating receptor stimulation exquisitely sensitive to inhibition of glucose-driven oxidative
phosphorylation (OXPHOS). IL-15 priming of NK cells can overcome metabolic requirements for NK cell
effector functions in vitro and in vivo, leading to metabolic flexibility evident as the ability to efficiently function
in the face of inhibition of key metabolic pathways. Our preliminary studies demonstrate activation-dependent
differences in the metabolic fuels and pathways required for NK cell effector functions in vitro and in vivo that
change with cytokine priming. We are interested in how cytokine priming leads to this metabolic `flexibility', with
a long-term goal of applying this knowledge to strategies for NK cell therapies. This proposal presents a 5 year
plan to investigate the metabolic regulation of NK cell activation. The specific aims of this proposal are to
investigate: 1) metabolic pathways upregulated during cytokine priming and the effects of glucose metabolism,
2) transcription factors regulating production of cytokine transcript in primed NK cells, and 3) metabolic
flexibility dependent on mTOR. We will use new inducible models with NK-specific deletion of key regulators of
metabolic pathways to rigorously test our hypotheses. The studies proposed here will advance our
understanding of how NK cells can be primed for metabolic flexibility and metabolic mechanisms important for
NK cell effector function, with a long-term goal of optimizing strategies to target NK cells for therapy of human
disease.

Public health relevance
Project Narrative Natural killer (NK) cells are immune cells that are poised to recognize and control viral infections and tumors through production of inflammatory cytokines and killing of infected cells or cancer cells. To carry out these functions, NK cells must rapidly upregulate pathways to induce their function, a process that requires metabolic fuels, or energy. The goal of this application is to identify metabolic pathways required for optimal NK cell function, with a long-term goal of using this knowledge to target NK cells to treat human disease.